Training Program in Translational Brain Tumor Research

Project Summary
The objective of this program is to provide predoctoral and postdoctoral training for individuals interested in
careers in translational brain tumor research. Despite the best efforts of neurosurgeons, neuro-oncologists,
and laboratory-based scientists, brain cancer remains among the most deadly of all malignancies.
Improvements in brain cancer therapy have come slowly, in part because of the relative dearth of individuals
trained in a manner that allows them to communicate with both clinicians and lab-based investigators. This is
a renewal application for years 16-20 of the T32 Training Grant in Translational Brain Tumor Research at the
University of California San Francisco. The UCSF Brain Tumor Center is the largest program in the nation that
focuses on developing translational brain tumor investigators of the future, individuals who can move
seamlessly between clinical and laboratory worlds and, in doing so, can more effectively contribute to the
development of new therapeutic interventions for brain tumors. We intend to build upon the training successes
in the previous cycles, maintaining the number of trainees and increasing the number of mentors. This
application requests support for a postdoctoral and predoctoral Training Program (two new postdoctoral
trainees and 2 new predoctoral trainees per year). The postdoctoral trainees are selected from the labs and
clinics of the faculty, and the predoc trainee is drawn from the top-tier students in the Biomedical Sciences
Program primarily. The faculty of the Program consists of 29 mentors (increased from 23 in the current cycle),
and a core of 25 research labs whose work has made the UCSF brain tumor community one of the most
productive and recognized in the world. Over the course of the years of support requested, the trainees work
with the PIs of these labs and clinics to develop and complete meaningful and significant translational brain
tumor research projects and, in the process, become fluent in laboratory-based and clinical research
techniques. The basic science trainees also have unique, supervised experiences in clinical neuropathology,
clinical neuro-oncology, clinical trial design, live neurosurgery, and we will pilot a new interventional
neuroradiology experience. At the same time, trainees take part in a faculty-led didactic curriculum uniquely
focused on brain tumor-related issues which allows trainees to develop a common language with which to
discuss and understand brain tumor biology, diagnostic and therapeutic modalities, and unresolved problems
in the field. Additional courses and training events that encourage effective speaking and writing are included,
and there is an extensive selection of existing courses to help tailor the educational experience of individual
trainees. Evaluation and mentoring mechanisms are included to help ensure success in the program and in
attaining future career goals. The UCSF T32 Program in Translational Brain Tumor Research has a strong track
record of attracting well-qualified individuals and successfully preparing investigators to lead translational brain
tumor research teams nationally and internationally and join in the fight against brain cancer.

Public health relevance
Project Relevance: Brain cancer continues to be a significant challenge to clinicians, with over 20,000 cases diagnosed per year, and the mortality rate still among the highest of all cancers. This proposal requests funds to support a training program that takes promising young investigators and trains them to understand brain tumor biology and therapy as an integrated whole. Investigators trained in this stimulating, translational, and comprehensive manner will provide competent leadership for future research efforts aimed at improved treatments and outcomes for brain tumor patients.